Partnership’s Community Outreach Research Education/Engagement Core (PCORE)

Over the next five years, PCORE will continue to bring together myriad communities, and researchers and students at CCNY and MSK, to build on our strong foundation of community-engaged approaches to develop, implement, and disseminate evidence-based cancer prevention and early detection practices. PCORE will also spearhead new, cutting-edge initiatives, including in cancer precision prevention/medicine. PCORE will seek to increase impact by focusing on translating data into policy to facilitate uptake of evidence-based practices into public health, clinical practice, and community settings. Overarching all PCORE activities is a consideration of the specific characteristics of the communities with which we work. AIM 1. To build upon and strengthen PCORE’s community-academic partnership assets and infrastructure to facilitate community engagement and community capacity building, and to extend our reach for the implementation and dissemination of cancer outcomes improvement activities: a) Strengthen and grow community-, faith-, and occupation-based organization partnerships and implement training activities to enable these organizations to independently
conduct cancer outcomes improvement activities; b) Deepen safety net health system partnerships (e.g. St. Barnabas Hospital Health System (a CUNY School of Medicine training site), Jamaica Hospital Medical Center, NYC H+H, FQHCs, MSK RLC), and the reach of the Mobile Health Unit (MHU) to expand the capacity to provide additional communities with cancer outcomes improvement activities; c) Support and collaborate with the U54 Partnership Cores, e.g., LinguistiC Responsiveness Shared Resource Core, the Research Education Core, and with the U54 Working Groups and the MSK P30 CCSG to engage communities, and CCNY and MSK researchers, to maximize bidirectional knowledge exchange, develop best practices, impact policy, and develop and implement targeted programs and studies. AIM 2. To leverage the expanded infrastructure developed in Aim 1 to further develop, implement, and disseminate robust i) community-engaged cancer outcomes improvement a) outreach, education, comprehensive screening packages that include precision prevention/precision medicine, and patient navigation into and through care, and b) research, and ii) policy development to address socioeconomic influences on cancer outcomes, changes in screening guidelines with evolving evidence, and differences in priority areas determined by community needs assessments: a) Precision prevention/precision medicine (e.g. immunotherapy, liquid biopsies, cancer genomics, targeted therapies) programs and research; b) Prevention-risk reduction (tobacco, obesity, diet, physical activity, occupation-linked risk); c) Screening and navigation into and through treatment for, and research on, colorectal, prostate, breast, lung, and HPV-associated cancers (focus on cervical and head and neck cancers).

Public health relevance
As per solicitation PAR-23-308 Comprehensive Partnerships to Advance Cancer Health Equity (CPACHE) (U54 Clinical Trial Optional) Project Narrative: Do not complete